Training and Experiential Learning in Biomedical Informatics (TExBioMed)

The University of Louisiana at Lafayette (UL) proposes the Training and Experiential Learning in Biomedical Informatics (TExBioMed) Summer Institute to increase education opportunities for students in biomedical informatics, health informatics, public health informatics, and related fields and strengthen and expand the nation’s capable workforce to meet the advances of the 21st Century. The next generation of multidisciplinary investigators will require foundational training and experience in life and physical sciences, as well as computational, mathematical, and engineering disciplines, to tackle increasingly complex problems that impact our health. This specialized training requires mentoring students early in their education (preferably undergraduates). TExBioMed, a research education initiative of the Louisiana Center for Health Innovation at UL, will leverage the institutional commitment to increasing research training by recruiting and immersing talented undergraduate students from multiple disciplines in a training environment that will expose them to the current state-of-the-art in biomedical informatics, health and public health informatics, and data science. TEXBioMed faculty members span four participating colleges and have complementary expertise in bioinformatics, health informatics, public health informatics, bioengineering, genomics, biology, chemistry, physics, mathematics, and computer science. This initiative will provide the participating students with unique, hands-on training and research experience to broaden their view of human health in post-genomic computational and data science research areas. The ultimate goal is to motivate these students to pursue careers in Biomedical Informatics/Data Science fields that will increase the talent pool to fulfill the nation’s current and future workforce needs.

Public health relevance
The next generation of multidisciplinary investigators will require foundational training and experience in both the life and physical sciences, as well as in computational, mathematical, and engineering disciplines, to tackle increasingly complex problems that impact our health. TExBioMed, an education research initiative of the Louisiana Center for Health Innovation at the University of Louisiana at Lafayette, will leverage the institutional commitment to increasing research training by recruiting and immersing talented undergraduate students from multiple disciplines in a training environment that will expose them to the current state-of-the-art in biomedical informatics, health and public health informatics, and data science. The program's ultimate goal is to increase the talent pool to fulfill the needs of the nation’s current and future workforce by providing the participating students with unique, hands-on training and research experience that will broaden their view of human health in post-genomic computational and data science research areas and motivate these students to pursue careers in Biomedical Informatics/Data Science fields.